Host-Microbe Co-Evolution in Human Health: The Microbiome-Pathobiont Continuum

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Host-Microbe Co-Evolution in Human Health:
The Microbiome-Pathobiont Continuum organized by Drs. Bana Jabri, Caetano Reis e Sousa and Philippe J.
Sansonetti, with scientific programming input from Keystone Symposia. The meeting will take place
February 18–21, 2025 at the Fairmont in Banff Springs, Banff, Alberta, Canada.
Mammals and microbes have co-evolved over 250 million years and host-microbial interactions are central to
health and disease. This meeting will cover how the human immune system responds to pathogens and
pathobionts while tolerating the presence of beneficial commensal organisms. Dysregulation of this delicate
equilibrium can lead to disease through loss of resistance to pathogens or loss of tolerance to commensals. This
meeting aims to build a community of scientists working on pathogens, commensals, microbial sensing, innate
immunity, evolution and disease pathogenesis to integrate knowledge and collectively address major questions
in the field. The interdisciplinary nature of the meeting and its focus on a diversity of microbial species will give
investigators a broader perspective on host-microbial interactions and encourage them to look beyond traditional
disciplinary boundaries to advance the treatment and prevention of infectious, immunologic and allergic
diseases. In addition, the conference will be held jointly with another Keystone Symposia conference, Human
Microbiome: Diversity, Selection and Adaptation, which will support new collaborations geared toward a more
comprehensive and integrative understanding of the holobiont.

Public health relevance
PROJECT NARRATIVE Over the past decade, there has been growing interest in understanding the significance of the microbiome, including the evolutionary relationships of hosts and microbes and the beneficial and pathogenic roles of microbes in human health and disease. This Keystone Symposia conference will examine the intricate interplay of bacteria and viruses with human systems to gain insights into how these interactions maintain health or mediate disease development. Together with another Keystone Symposia conference, Human Microbiome: Diversity, Selection and Adaptation, this conference will focus on the fundamental mechanisms of microbiome establishment, diversity and evolution and their links to normal and pathogenic interactions between microbes and humans.